The impact of coding region variants on mutant p53 biology

Project Summary
It is now well accepted that tumor-­derived mutant forms of p53 are potently oncogenic. Silencing mutant
p53, or inducing the degradation of this protein, can markedly impair tumor growth in vitro and tumor
progression in vivo. The ability of mutant p53 to drive tumor progression is frequently mediated by protein-­
protein interaction, and this is often referred to as the “gain of function” (GOF) activity of mutant p53. One
of our gaps in knowledge has been the identification of key GOF activities of mutant p53. Another has
been investigation into how coding region SNPs (single nucleotide polymorphisms) in p53 influence the
mutant p53 GOF. One of the Holy Grails of cancer biology has been the identification of compounds that
can reactivate the p53 pathway in tumors containing mutant p53, by refolding mutant forms of p53 into wild
type conformation and activity. Several groups have reported the identification of compounds that act in
these ways. Another key gap in our knowledge has been how coding region SNPs (single nucleotide
polymorphisms) in p53 impact the folding of mutant p53, and the efficacy of compounds that refold mutant
p53.
In this application, we take aim at two coding region SNPs in p53: Pro72Arg and Tyr107His. We recently
published that the codon 72 variation is a potent intragenic modifier of mutant p53 GOF. Specifically, the
Arg (R72) variant of mutant p53 is a superior mediator of tumor cell invasiveness and is associated with
poor prognosis in women with breast cancer. We will delve into an investigation of the influence of this
SNP on mutant p53 GOF, using novel mouse models for the R175H mutation, containing either P72 or
R72. We will learn their impact on p53 structure using NMR, and on their influence on the efficacy of p53-­
refolding compounds. This aim constitutes a structural, molecular and in vivo analysis of the codon 72
SNP of mutant p53.
We have obtained data that the Y017H variant of p53 alters the structure and activity of this protein. We
will explore the effect of this African-­specific SNP on p53 function in a novel mouse model. We have
identified genes with impaired transactivation by Y107H, including the chromatin modifier PADI4;; we will
explore its impact on p53 function and tumor suppression. In sum, for both aims we employ a combination
of gene expression, protein-­protein interaction, cytotoxicity and novel mouse models. We have recruited
expert collaborators like Donna George (Penn), John Karanicolas (Fox Chase Cancer Center) and
Darren Carpizo (Rutgers-­Cancer Institute of New Jersey). These Investigators bring to bear their
complimentary expertise to address an important and clinically-­relevant question: how can we better
harness p53 to eradicate cancer.

Public health relevance
Project Narrative The proposed research will conduct the first comprehensive analysis designed to definitively assess the influence of the codon 72 SNP on mutant p53 GOF, and on the efficacy of p53- refolding compounds. It will also define the impact of the Y107H African- specific SNP within the p53 DNA binding domain on p53 structure and function using NMR and a novel mouse model. This research has important implications for understanding cancer risk in under- represented populations, and for informing personalized medicine approaches.